Identifying Phenotypes in Carpometacarpal Osteoarthritis through Pain, Biomechanics, and Machine Learning Analyses

PROJECT SUMMARY/ABSTRACT
Carpometacarpal osteoarthritis (CMC OA) is a leading cause of global disability, causing significant functional
limitations and pain, as well as decreased quality of life. Current treatment options fail to adequately address
disease impact, offering limited pain relief, only temporary functional stability, and/or debilitating constraints to
the physiologic thumb joint. There is a need to develop novel therapies based on the biomechanical and
somatosensory factors that influence CMC OA disease progression.
CMC OA is a multifaceted disease with heterogeneous symptom presentation. There is limited research
appropriately evaluating biomechanics and pain in CMC OA, despite their combined influence on disease impact.
Current biomechanics and pain research allows for robust analysis of functional limitations and somatosensory
deficits. A comprehensive evaluation of structure, function, and pain in CMC OA is needed to fully understand
disease impact and properly address diagnostic and treatment concerns. The proposed research will provide an
innovative evaluation of function and pain in CMC OA by (1) determining a direct relationship through movement-
evoked pain (MEP) analysis and (2) utilizing advanced machine learning algorithms to identify the complex
relationships in biomechanical and somatosensory data, define patient phenotypes, and predict symptoms.
Implementing kinematic, kinetic, and muscle activity analysis with MEP will innovatively relate robust
biomechanics research with pain for CMC OA (Aim 1). The results from this aim will identify compensatory
movement patterns that alleviate pain, thereby informing alternative and effective therapies. Implementing
machine learning algorithms to evaluate complex, multifaceted clinical data will allow for the evaluation of
heterogeneous symptomology unique to CMC OA (Aim 2 and 3). Utilizing probabilistic cluster analysis and
explainable AI (XAI) will increase transparency and confidence in the interpretation of clinical data by identifying
the variables driving model prediction. These variables will be used to distinguish patient phenotypes and
understand the mechanisms underlying disease progression. The results from these aims will inform current
diagnostic standards for CMC OA and lay the groundwork for predictive prognostic models.
Overall, the aims proposed in this research work harmoniously to provide a holistic evaluation of CMC OA
disease impact. The results of this research will advance scientific knowledge of the factors that influence
disease: structure, function, and pain. This F30 fellowship will provide the applicant with an exceptional
foundation in biomechanics and advanced data science techniques. The skills developed through the applicant's
training plan will prepare her for a career developing personalized rehabilitation strategies as a Physical Medicine
and Rehabilitation (PM&R) physician-scientist.

Public health relevance
PROJECT NARRATIVE Carpometacarpal osteoarthritis (CMC OA) is a leading cause of global disability with limited treatment options. There is a need for holistic evaluation of this disease to understand the relationship between structural degeneration of the joint, functional ability, and pain. The proposed research will comprehensively evaluate the biomechanical and somatosensory implications of CMC OA and utilize machine learning to identify alternative diagnosis, evaluation, and treatment methods, thereby informing more effective management of CMC OA in the future.